CODEX multiplex immunofluorescence imaging system

Project Summary/Abstract:
In this proposal we request funding to purchase an Akoya PhenoCycler Fusion imaging system for the Rutgers
New Jersey Medical School (NJMS) Cellular Imaging and Histology Core facility. This system will provide the
NJMS research community, as well as investigators in other Rutgers schools with state-of-the-art CO-Detection
by IndEXing (CODEX) multiplex imaging technology. The Akoya PhenoCycler Fusion imaging system includes
Akoya’s PhenoCycler, a custom designed automated microscope stage-top fluid exchange instrument and
PhenoImager Fusion, an upright slide scanning epifluorescent microscope. This system will allow for the labeling
of up to 60 individual biomarkers in single tissue section using oligonucleotide-conjugated antibodies against
specific antigens. Tissues are stained once with all the barcoded primary antibodies, which can then be detected
using complementary reporter DNA sequences conjugated to fluorescent dyes. Up to three of these fluorescent
reporters can be imaged in a single CODEX cycle and then removed using a mild stripping buffer. Another
CODEX cycle can then be started with three different oligonucleotides conjugated to the same reporters and the
process can be repeated until all of the antigens of interest have been imaged. The investigators in this shared
instrumentation grant have extensive experience using immunofluorescence or immunohistochemistry, and their
research programs would substantially benefit from a multiplex imaging system to resolve spatial interactions
between various cell types and immune cell subsets. Specifically, several investigators study the immune
response to infection and inflammation, in which the recruitment or interactions of different innate and adaptive
immune cells is involved in the pathology or resolution of disease. Additionally, several investigators are
advancing our understanding of how specific cell types respond to local paracrine signals involved in antifungal
immunity or within the nervous system. In all of these areas, the ability of the Akoya PhenoCycler Fusion imaging
system to image up to 60 targets with single cell resolution will provide clear benefits over traditional fluorescence
microscopy and provide the spatial information that is lacking from high-dimensional flow cytometry. Akoya’s
ability to offer an integrated multiplex microscopic imaging system that minimizes damage to the tissue sections
and is compatible with commercially available antibodies has led us to favor CODEX technology over other cyclic
immunofluorescent techniques, such as Cytiva’s CellDive and Miltenyi’s MACSima platforms. Overall, the Akoya
PhenoCycler Fusion imaging system would provide investigators at the New Jersey Medical School and the
wider Rutgers community with much needed multiplex immunohistochemistry capabilities.

Public health relevance
Project Narrative: The Rutgers New Jersey Medical School Cellular Imaging and Histology Core Facility requests funding to purchase an Akoya PhenoCycler Fusion multiplex immunofluorescence imaging system using CO-Detection by IndEXing (CODEX) technology, which will be used by multiple investigators at Rutgers University. This technology will allow for enhanced cellular phenotyping and quantification of spatial interactions between individual cells within tissues. Investigators will study disease-related processes including host-pathogen interactions, immune processes, neurobiology, liver and gastrointestinal disorders.